Role of O-GlcNAcome on Breast Cancer Initiating Cells

Project Summary
It is widely accepted that tumors are highly heterogeneous. There is a subpopulation of cells in a tumor, called
tumor-initiating cell, that can be isolated and are able to self-renew, differentiate and form the bulk of the tumor.
Many cancers don’t respond to traditional chemotherapy or radiotherapy, and those that initially
respond, often relapse. Conventional therapy only attacks proliferating cells, leaving behind a pool of resistant
stem-like cells that are able to regenerate the whole tumor. Understanding mechanisms that regulate
tumor-initiating activity will lead to designing and developing effective therapeutics. Our lab has demonstrated
for the first time that the nutrient sensor O-GlcNAc transferase (OGT) regulates cancer-initiating cells in vitro
and in vivo. Reducing OGT, genetically or pharmacologically, blocks mammosphere formation in vitro
and reduced epithelial-mesechymal markers (EMT), cancer stem cell markers. Importantly,
overexpression of OGT, in multiple breast cancer cells, increases cancer stem cell markers including
NANOG, increases mammosphere formation in vitro and increases tumor initiation in vivo. In this
proposal, we hope to uncover molecular mechanism by which OGT regulates tumor initiation, by in
part, understanding OGT interactome and O-GlcNAcome in breast cancer tumor initiating cells. This
information will allow us to identify novel therapeutic targets in treating cancer and reverse drug resistance.
Based on our preliminary results, the central hypothesis of this application is that the nutrient sensor O-
GlcNAc transferase plays a fundamental role in breast cancer initiating cells via, in part, NANOG
regulation. Completion of these experiments will contribute to our understanding of how nutrient-sensing
pathways connects at the molecular level to self-renewing cancer stem cells (CSCs) and providing a
framework for understanding how cancer alterations in metabolic pathways regulate core self-renewal
signaling that controls CSC maintenance. In Aim #1, we will determine the molecular basis of OGT/O-
GlcNAc regulation of the master CSC regulator NANOG. This aim will determine the molecular basis of OGT
regulation of NANOG in breast cancer tumor initiating cells.In Aim #2, we will Identify OGT interactome/O-
GlcNAcome between between cancer cells and cancer stem cells. This aim will identify OGT interacting
proteins and O-GlcNAcylated protein in tumor initiating cells to identify novel pathways and regulators
of tumor-initiating ability. The final aim will evaluate the role of OGT in regulating tumor-initiating
activity in vivo. Importantly, we will test novel OGT inhibitors in preclinical cancer models and test
whether OGT targeting drugs as potential anti-tumor initiation cell therapeutic strategy against breast
cancer growth and metastasis in vivo. These studies will further our understanding of how metabolic
reprogramming in cancer cells connects at the molecular level to tumor initiating cells and will create
mechanistic understanding of how nutrient sensor OGT can couple to cancer initiation pathways and
establish OGT as therapeutic target for treatment of resistant cancers.

Public health relevance
Project Narrative This grant will help elucidate mechanisms of how glycosylation regulates pathways of cancer initiation. Specifically, we will focus on how O-GlcNAcylation regulates tumor-initiation pathways. Additionally, we will test novel agents for their anti-tumor properties thus this proposal may help establish a new therapeutic target for treatment of cancer.